SPATIO TEMPORAL CHANGES IN CEREBRAL HEMODYNAMICS AS MANIFESTED IN FMRI

Temporal studies were performed both to understand spatiotemporal characteristics of signal in fMRI images and to examine temporal evolution of neuronal processing. In a time-resolved study of the visual system, the nature of the spatiotemporal characteristics of functional magnetic resonance imaging was examined using sophisticated mathematical tools. This study revealed a rich spatiotemporal structure in the stimulus related changes even for a very simple visual stimulation protocol, suggesting that distinct structures respond differently to the stimulus. In addition to revealing the temporal characteristics, this work also presented a number of novel mathematical approaches for processing the data, including a novel approach for removing gross motion artifact.